Using a System-Wide Database to Reduce Workplace Violence in Hospitals

Project Summary/Abstract Violence towards health care workers in general hospital environments is a significant occupational hazard that threatens employee safety, health, work productivity, retention, and the quality of care. NIOSH has established strategic goals aimed at the reduction of psychologically unhealthy work environments generally, and workplace violence specifically, among the 17 million employees within the Health Care and Social Assistance sector. [However, hospitals lack practical and sustainable systems for workplace violence risk assessment and prevention. There is a pressing need for standardization of workplace violence data collection, epidemiological risk analysis, and translation of collected data into effective violence prevention efforts.] The long-term objective of this proposal is to develop standardized methodology for workplace violence surveillance, risk assessment, and prevention. The specific aims of this project are to: (1) Develop and evaluate standardized, database-generated reports of documented violent incidents attuned to end-user specifications by representatives of hospital safety, occupational health, nursing, security, human resources, [and labor]; (2) Develop and implement strategies [using the CDC/NIOSH Hazard Risk Matrix] for [studying database data and] helping hospital management [and labor] to prioritize [worksites for] violence interventions; and (3) Prospectively evaluate the effect of [a worksite walkthrough] intervention by comparing [violence incidence and injury rates, work satisfaction, and staff-perceived work safety culture at [randomized] intervention and control worksites]. This work will be carried out within a multi-site metropolitan hospital system with 14,500 employees. In previous work with the hospital system's [unique] database, this research team has developed methodology for calculating incidence rates and risk factors for [workplace] violence. The proposed participatory action research project will build further on that methodology, utilizing the existing electronic data collection system and database, and working in active collaboration with occupational health, safety, nursing, security, human resource and labor professionals within the hospital system. Using focus group discussions, we will develop user-[adapted], standardized, computer-generated reports of workplace violence incidence rates and risk factors based on the specifications of these [key hospital system stakeholders]. In the next phase, these workplace violence reports will be studied using the Hazard Risk Matrix as a framework for assessing priorities for allocation of violence prevention efforts. Based on the group's analysis, [a violence intervention in the form of a worksite walkthrough] will be implemented and evaluated, using a [randomized] design. Results from this research could potentially be the foundation for a standardized methodology for workplace violence surveillance, risk assessment and prevention that could be used in hospital systems nationwide [to improve worker health and safety].

Public health relevance
Project Narrative Workplace violence towards health care workers is an occupational hazard of epidemic proportion, significantly threatening the health and safety of 17 million employees. A critical barrier to [managing] this public health problem is a lack of effective methods for collecting, analyzing and [utilizing] data on violent events [in hospitals]. [If successful, this project will deliver an integrated system for standardized violence surveillance and worksite-adapted intervention with applicability for hospitals nationwide.] __SpecificAimsTextDelimiter__ 2. Specific aims Violence towards health care workers in general hospital environments is a significant occupational hazard that threatens employee safety, health, work productivity, retention, and the quality of care. Official statistics indicate that the rate of non-fatal assault is four times greater among hospital workers, compared to all private-sector workers. [Despite established federal OSHA violence prevention guidelines for the health care sector, hospitals lack practical and sustainable systems for workplace violence prevention. There is a pressing need for standardization of workplace violence data collection, epidemiological risk analysis, and translation of collected data into effective violence prevention systems]. [For the past two years, our research team has worked with a large metropolitan hospital system in developing a unique electronic database of worker-reported incidents of workplace violence. By linking the database with the hospital system's human resources database, we have developed methodology for ongoing calculation of incidence rates of workplace violence based on person-time at risk.] The proposed project will further develop the existing data collection system and database, working in active collaboration with [hospital system management and labor]. The long-term objective of this proposal is to develop standardized [and sustainable] methodology for workplace violence surveillance, risk assessment, and [prevention]. The goals are to (1) develop user-friendly, standardized data reports depicting current rates and risk factors for workplace violence in hospital settings; (2) develop [fact-based] hazard risk assessment strategies for determining where violence interventions are most needed; and (3) [evaluate the impact of worksite walkthroughs on violence incidence, injury, work safety and satisfaction]. The expected outcome of this proposed participatory action research project is [a standardized system for workplace violence data collection, hazard evaluation, and worksite intervention in hospitals. Close collaboration with key hospital system stakeholders will ensure the relevance and feasibility of all aspects of the violence prevention system]. The results of this project will fill a high priority gap in hospital workplace violence prevention by establishing [evidence-based] methods for translating violence surveillance data into fact-based risk reduction and prevention efforts. The specific aims of this project are to: 1. Develop and evaluate standardized, database-generated reports of documented violent incidents attuned to end-user specifications by [representatives] of hospital safety, occupational health, nursing, security, human resources, [and labor]. Based on preliminary data, we hypothesize that key elements of the reports will include violence incidence rates over time per hospital, professional group, [worksite], and type [and severity] of violence. 2. Develop and implement strategies for prioritizing [worksites for a walkthrough violence intervention using database reports and the CDC/NIOSH Hazard Risk Matrix]. We expect this framework to enable [hospital management and labor] to categorize the risks [and severity] of hospital workplace violence [and to identify worksites most likely to benefit from an intervention]. 3. Prospectively evaluate the [impact of a standardized walkthrough intervention] by comparing [violence incidence and injury rates and staff perceptions of work satisfaction and safety culture at randomized intervention and control worksites] within the hospital system. We predict reduced [violence and injury rates and higher satisfaction and safety culture ratings at intervention sites compared to controls post-intervention]. Our research team has extensive experience in healthcare violence research, having conducted one of the only large-scale, randomized controlled interventions in high-risk environments [Arnetz & Arnetz 2000]. This work will build on a well-established collaboration between the research team and occupational health and safety experts in a large multi-site hospital system. The proposal is innovative in that it applies [population-based workplace violence data to both risk analysis and intervention [implementation]. Results from this participatory action research could potentially be the foundation for a standardized methodology for workplace violence surveillance, intervention and follow-up that could be used in hospital systems nationwide [with significant positive impact on the health and workplace safety of health care workers].